CIRI Oncology Research Alliance

PROJECT SUMMARY/ABSTRACT
The Catholic Health Initiatives’ (CHI) Institute for Research and Innovation (CIRI) Oncology Research Alliance
(CORA) seeks to continue to support and expand a community-based cancer research network, currently
across nine states, made up of community hospitals and cancer centers and incorporate best practices in
enrolling patients to National Cancer Institute (NCI)-sponsored cancer control, prevention, and care delivery
clinical trials and other human subjects’ studies. The specific aims are: to the increase enrollment in cancer
control, prevention and care delivery clinical trials by providing access to a wide portfolio of high quality
research studies that meet the needs of CORA’s diverse populations, annually accruing 10% of new cancer
cases within the populations served by the network; identify, design and implement cancer care delivery
research (CCDR) that leads to improved models of care and translates to high quality, value-based services
throughout the oncology continuum; and expand efforts to explore and address the cancer care needs of racial
and ethnic minorities as well as other underrepresented populations. Applying CIRI’s innovative, centralized
and standardized organizational research model encompassing a network of geographically diverse
community cancer programs, CIRI will continue to provide the necessary resources for amplifying clinical trials
across the country. CORA’s geographic reach and involvement with diverse Primary and Sub-Affiliates allow it
to offer a wide portfolio of trials to large, established programs as well as small, rural sites and new regions that
historically have had limited access to cancer clinical trials. Applying best practices from CORA to all current
and new Primary and Sub-Affiliates along with increased physician engagement will increase the number of
patients screened and enrolled in clinical trials. Leveraging CHI’s unique, well-positioned standard oncology
electronic health records (OEHR), enterprise data warehouse, and analytics capability will continue to give
CORA the depth of data and access to information needed to expand CCDR. CHI's OEHR at CORA sites yield
accessible data across the network that feeds into the data warehouse. CHI’s single network tumor registry
database and OEHR make CORA responsive to requests for data around patterns of care. Lastly, the
advanced patient navigation, survivorship, and multidisciplinary conferences and disease site specific tumor
boards already in place at all Primary and Sub-Affiliate sites will support this research. Expanding to additional
health systems and sites, and adding new investigators as opportunities arise will increase the number of
patients from underrepresented populations that CORA can screen for enrollment in cancer clinical trials.
CORA Primary and Sub-Affiliates’ community outreach coordinators’ and navigators’ integrated efforts will be
utilized to improve cancer control and prevention, detection, care delivery, and treatment for these populations.
Continued growth of CORA’s community partner networks, cultural sensitivity, translation support and nurse
navigation training at all Primary and Sub-Affiliate sites will help eliminate barriers to care.

Public health relevance
The Catholic Health Initiatives’ Institute for Research and Innovation (CIRI) Oncology Research Alliance (CORA) is a community-based research network made up of community hospitals and cancer centers from ten states that works together to recruit and enroll patients, including those underrepresented in research, in cancer control, prevention, screening, and care delivery trails as well as quality-of-life studies. CORA also identifies, designs and implements cancer care delivery research that leads to improved models of care and translates to high quality, value- based services throughout the oncology continuum. Overall, CORA seeks to contribute to and improve cancer research and the delivery of cancer care in the community.